Non-canonical role of GRK2 in mediating cardiac function

Project Summary Heart failure (HF) is common in patients with metabolic syndromes, most notably diabetes. In these patients, glucose resistance and/or imbalanced peptide hormone signaling impairs glucose utilization by the heart. As the diabetic heart increasingly resists glucose uptake, it increasingly relies on fatty acids for energy production. However, the latter can promote lipotoxicity, prompting the heart to further rely on other more limiting substrates. Like a car running out of fuel, the ability of the heart to utilize these metabolic substrates plays a vital role in cardiac contraction and function, particularly during cardiac injury. This phenomenon becomes particularly evident in diabetic patients, yet mechanisms detailing how islet dysfunction crosstalk and impact cardiac signaling pathways remain poorly understood. Cardiac G-protein coupled Receptor Kinase-2 (GRK2) is a known regulator of cardiac contraction and its upregulation in myocardial tissue is linked to the development of HF. In addition to its canonical role in GPCR regulation, non-canonical GRK2 regulates metabolism that may contribute to HF. Recent studies have reported that diabetic patients have increased GRK2 levels in the heart, but interestingly, GRK2 levels in diabetic pancreata is decreased. As GRK2 can alter the metabolism of cardiac cells, loss of GRK2 in pancreatic cells may disrupt metabolic processes that are important for insulin and glucagon secretion. Since the pancreas is the sole source of insulin and glucagon, and little is known about GRK2 signaling in the pancreas, this proposal seeks to understand how GRK2 regulates metabolic signaling pathways and hormone secretion from the pancreas, and by extension, cardiac substrate utilization and metabolism. To answer these questions, this proposal integrates biochemical and functional techniques with three novel genetic mouse models of GRK2, including inducible GRK2 knockout models that specifically target α or β cells in the pancreas. This proposal hypothesizes that GRK2 regulates several metabolic signals from the pancreas to the heart that intimately link cardiac metabolism and contractile function. Due to the specialized nature of islets, the proposal also hypothesizes that pancreatic GRK2 signaling differs substantially from known functions of cardiac GRK2 signaling. Specifically, this proposal will: (i) examine whether GRK2 downregulation in the pancreas alters cardiac function and metabolism; and (ii) determine how GRK2 participates in islet function. Cardiac functional analysis will be performed by echocardiography and pressure-volume loops. In vitro studies in adult cardiomyocytes and primary islets will be used to delineate GRK2 mechanism of action in these cells. Glucose dynamics and islet function will also be studied in our mouse models using glucose and insulin assays that include tolerance tests, islet perifusions, glucose telemetry, and hyperinsulinemic/hyperglycemic clamps. Overall, this work will illuminate GRK2-mediated mechanisms that regulate crosstalk between the pancreas and heart, with the overarching goal of unraveling novel treatment strategies for HF patients with diabetes.

Public health relevance
Project Narrative The G-protein coupled receptor kinase 2 (GRK2) is a master-regulator of cell physiology, which has been shown to be upregulated in heart failure and diabetes. In this research grant, we seek to determine the role of pancreatic GRK2 in eliciting metabolic signals to the heart. Our research fills several conceptual gaps important to understanding the functional link between the pancreas-heart axis of communication.